Using CRISPR-Cas9 genetic abscission in vivo to study the role of GABA-A receptors of the thalamic reticular nucleus in regulating non-rapid-eye-movement sleep and drug induced sleep

This basic research proposal in mice dissects the neural circuitry and receptors that underlie therapeutic vs
side effects of the sleep medicines used to treat Veterans, using a state-of-the-art gene editing approach called
clustered regularly interspaced short palindromic repeats (CRISPR). The support of this CDA2 award would
allow the applicant to be trained in in vivo reverse microdialysis and in vitro electrophysiology to allow him to
comprehensively validate his genetic manipulations and dissection of neurocircuits, and would allow him to
become a leader in pre-clinical sleep research within the VA.
Disturbed sleep occurs in neuro-psychiatric illnesses such as insomnia, sleep apnea, post-traumatic
stress disorder and traumatic brain injury. United States Veterans have more than double the amount of sleep
disturbance compared to the rest of the population. As a result, sleep medicines like zolpidem (Ambien) and
eszopiclone (Lunesta) are prescribed widely to Veterans. From 2005 to 2014, VA prescriptions of zolpidem
increased nearly 7 times, and VA prescriptions of eszopiclone increased over 100 times for men and over 50
times for women Veterans. However, these medications do not promote a natural sleep and have side effects.
Thus, a better understanding of their mechanism of action is needed to develop better treatments.
Delta waves are slow brain rhythms at the speed of 0.5 to 4 waves per second, and large amounts of
these waves are a defining feature of `deep' NREM sleep. Delta waves are linked to the restorative aspects of
deep sleep (mood regulation, synaptic homeostasis, cellular energy regulation and clearance of toxic proteins).
Problematically, zolpidem and eszopiclone induce `light' sleep and drastically reduce NREM delta waves. So
perhaps unsurprisingly, these drugs are linked to suicide risk and cognitive problems. Delta waves are
recorded from the cerebral cortex by electroencephalography, but they are generated deep within the brain's
core structure, the thalamus. Excitatory “Thalamocortical (TC)” neurons form the connections from the
thalamus to the cortex, and they act as delta wave pacemakers. But they require an inhibitory drive to perform
this function. This inhibitory drive is provided by the neurotransmitter GABA, which comes from an outer shell-
like part of the thalamus called the thalamic reticular nucleus (TRN). Recent discoveries have shown that a
stimulated TRN promotes delta waves. TRN neurons themselves, receive GABA from wake active neurons in
the basal forebrain and lateral hypothalamus. With this in mind, we will test a hypothesis that GABAergic
inhibition onto TRN regulates delta waves via GABAergic inhibition onto TC neurons. This will be the 1st study
in this topic that dissects molecular, cellular, and brain-region specific mechanisms simultaneously in vivo.
α3 subunits are a major structural component of the type of GABAA receptors that are native to TRN. In
Specific Aim (SA) 1 we use CRISPR-Cas9 to locally ablate α3 subunits within a subset of TRN neurons that
are defined by the presence of a calcium-binding protein called parvalbumin (PV). Our preliminary data shows
that disrupting this GABA transmission increases NREM delta waves and promotes NREM in vivo; and
reduces spontaneous inhibitory post synaptic currents (sIPSC) in vitro. To add rigor and reproducibility, we use
an alternative mouse genetic approach to overexpress α3 subunits in PV+ TRN neurons. Training will enable
the in vitro work. In SA2 we use CRISPR-Cas9 to locally ablate α1 subunits, which form the type of GABAA
receptors that are native to TC neurons. Here we focus on the paraventricular thalamus, which is involved in
stress-induced arousal. We will also overexpress α1 in the TC neurons. In vitro data will be collected during the
training. In SA3 Dr Uygun will train to use in vivo reverse microdialysis to locally administer eszolpiclone and
zolpidem to TRN and TC neurons. This will examine the delta suppressing component of sleep medicines.
This work will guide the development of next-generation GABAergic sleep medicines, leading to
improved Veteran patient care with lower suicide risk and better mood and cognitive performance.

Public health relevance
U.S. Veterans have higher than usual rates of certain illnesses including insomnia, sleep apnea, post-traumatic stress disorder and traumatic brain injury, these all involve sleep disturbance. Because of this, many Veterans are given prescription sleep medicines, and the number of these cases has increased rapidly in recent years. Brain waves of various speeds correspond to behaviors and/or brain function. Deep and restorative Non- Rapid-Eye-Movement sleep is characterized by so called delta waves, these are slow, and they are good for mental health, memory and clear thinking. Unfortunately, modern sleep medicines reduce these healthy waves. This could be a contributing factor in why today's sleep medicines are often linked to suicide risk and mental problems. Using a cutting-edge genetic engineering tool called CRISPR-Cas9, I will examine neurocircuitry governing therapeutic effects vs side effects of sleep medicines. This pre-clinical work will lay the foundation for developing next-generation medicines, that will provide better care for our Veterans.